OPTIMIZING RETENTION, DURATION&DISCONTINUATION STRATEGIES FOR OPIOID USE DISORDER PHARMACOTHERAPY (CTN-0100). 03/01/2020 - 08/15/2022. N01DA-19-2250.T

OPTIMIZING RETENTION, DURATION&DISCONTINUATION STRATEGIES FOR OPIOID USE DISORDER PHARMACOTHERAPY (CTN-0100).